Radiomic biomarkers for clinical decision support that predict patient outcomes in serous ovarian carcinoma

ABSTRACT
Less than a third of women diagnosed with advanced epithelial ovarian cancer (EOC) survive five years after
diagnosis. Despite therapeutic improvements over time, patient survival has remained relatively unchanged for
decades. At present, we are unable to predict which EOC patients are at-risk for adverse outcomes following
first-line treatment. Thus, there remains a critical unmet need to identify innovative biomarkers for clinical
decision support that will achieve optimal outcomes in this deadly disease. As part of standard of care (SOC) for
EOC, computed tomography (CT) is used for diagnosis, prior to initiation of treatment, and to monitor treatment
response and patient outcomes. SOC CT images can be converted into quantitative data that can be used as
rapid, reproducible, and accurate non-invasive biomarkers for clinical decision support in the cancer care
continuum. The present proposal will utilize an extensively validated radiomics imaging pipeline developed by
our group and standard medical imaging software to measure body composition to identify image-based
biomarkers that predict survival among patients with high-grade serous ovarian carcinoma (HGSOC). We will
focus on HGSOC as it is the most common histotype of EOC and typically responds favorably to first-line
chemotherapy but >80% of patients experience recurrence. In Aim 1, we will build upon ongoing efforts to
establish a multi-institutional cohort of racially and ethnically diverse women with HGSOC with pre-treatment
SOC CT images and well-annotated clinical and outcomes data. Using validated radiomic pipelines developed
by our team, regions of interest (i.e., the primary ovarian tumor) from pre-treatment CT scans will be identified
and segmented, and image features will be calculated including radiomics and body composition depots (skeletal
muscle mass and subcutaneous, visceral, intra/intermuscular, and total adipose tissue). This multi-institutional
cohort will be utilized to identify and validate CT image-based features that predict survival among HGSOC
patients (Aim 2). We will further test the predictive model from Aim 2 and develop de novo models among
clinically relevant sub-groups of women with HGSOC, including racial and ethnic groups and women treated with
neoadjuvant chemotherapy vs. upfront surgical debulking as first-line therapy (Aim 3). This work will provide
readily calculable, non-invasive biomarkers from SOC CT images for clinically translational information to better
predict which patients may fail first-line therapy and to support patient therapy stratification. Ultimately, with
sufficient testing and validation, our long-term goal is to validate clinical-imaging models that could be
incorporated into clinical care to improve outcomes among HGSOC patients.

Public health relevance
PROJECT NARRATIVE Ovarian cancer is the deadliest gynecologic malignancy in the U.S. and innovative approaches for achieving optimal outcomes are desperately needed. We propose to establish a multi-institutional cohort of racially and ethnically diverse women with the most common and one of the deadliest histotypes of ovarian cancer, high- grade serous ovarian cancer (HGSOC), with standard of care (SOC) computed tomography (CT) images prior to treatment and well-annotated clinical and outcomes data to identify and validate image-based features predictive of survival. This work will provide readily calculable, non-invasive biomarkers from SOC CT images for clinically translational information to aid in patient stratification efforts that will ultimately improve outcomes among women with HGSOC.